Elucidate the landscape of druggable targets for eliminating cancer persister cells

PROJECT SUMMARY
Residual disease, caused by incomplete killing of cancer cell populations, is a critical limitation of targeted
therapy, and almost inevitability leads to tumor recurrence. A growing body of evidence suggests a significant
contribution of persister cells to residual disease. Persister cells are small subpopulations of the original tumor
that survive presumed lethal doses of targeted therapy via non-genetic mechanisms of drug tolerance.
Eliminating persister populations before they have a chance to evolve genetic resistance mutations will improve
the durability of targeted therapies. However, signals that promote and targets that eliminate persistence are
poorly characterized.
Our goal is to elucidate mechanisms of persister rewiring and pinpoint druggable targets to eradicate persistence
in KRAS-mutant non-small cell lung cancer. Our aims are designed to: (Aim 1) illuminate signals that promote
persistence in physiopathological contexts; (Aim 2) identify and validate targets that inhibit persistence; and (Aim
3) establish a persister knowledge base and AI-enabled tools to continuously generate target hypotheses.
Elucidating pro-persistence signals and nominating preclinically validated drug targets will enable rational design
of combination treatment strategies that limit opportunities for resistance to evolve with KRAS G12C drug-treated
NSCLC.

Public health relevance
PROJECT NARRATIVE Incomplete killing of cancer cell populations is a critical limitation of targeted therapy treatment, and almost inevitably leads to disease recurrence. A growing body of evidence implicates the contribution of non-genetic mechanisms in residual disease. Our study is designed to identify signals that promote and targets that eliminate these non-genetic sources of residual disease in KRAS-mutant non-small cell lung cancer.